NH CREATES the Future: The New Hampshire Collaborative for Regenerative Medicine Education and Training for Engineers and Scientists of the Future

Project Summary
NH CREATES the Future: the NH Collaborative for Regenerative Medicine Education
and Training for Engineers and Scientists of the Future
The University of New Hampshire, in collaboration with faculty participants from the New
Hampshire IDeA Network of Biomedical Research Excellence (NH-INBRE), as well as
school district and industry partners, propose an NIH Science Education Partnership Award
to establish and advance NH CREATES the Future: the NH Collaborative for Regenerative
Medicine Education and Training for Engineers and Scientists of the Future (hereafter, NH
CREATES). The overall goal of NH CREATES is to establish a robust pipeline extending
from middle school to higher education for the burgeoning regenerative medicine and
biofabrication (RM&B) industry in New Hampshire. Aim 1 of NH CREATES will provide
formal professional development and training for twelve grades 6-12 teachers per year, in
project-based learning implementation through the lens of RM&B and its foundational concepts,
(1) organisms for regeneration, (2) cellular and molecular biology, (3) computational methods in
biology, and (4) molecular structure and function, as well as responsible conduct of research.
Aim 2 provides a set of summer programs for forty under-represented youth annually,
incorporating project-based learning that is focused on RM&B. This specific platform will also
provide a forum where parents, school administrators and industry partners can bring students
into a community of near-peer mentors, to establish them on a biotechnology career pathway.
Additionally, these youth project support the teacher training by serving as a learning laboratory
for the professional development of the teachers.
Moreover, aim 3 of NH CREATES will
establish a NH CREATES Ecosystem, to provide an infrastructure that will build relationships
and develop connections between educational institutions within NH INBRE, school teachers
and administrators, parents, youth, employers, community resources, and philanthropy. The
combination of these stakeholder relationships and their activities establish an innovative
ecosystem in New Hampshire that facilitates the entry and retention of students in a
biomedical education pipeline spanning middle school to higher education, in order to
sustain the workforce to meet NH’s RM&B and biotechnology needs. NH CREATES is a
training mechanism to supply the RM&B industry with an educated workforce so that, in turn,
this burgeoning industry can fulfill its potential to cure disease.

Public health relevance
NIH SEPA Project Narrative The University of New Hampshire, in collaboration with faculty participants from the New Hampshire IDeA Network of Biomedical Research Excellence (NH-INBRE), as well as school district and industry partners, propose an NIH Science Education Partnership Award to establish and advance NH CREATES the Future: the NH Collaborative for Regenerative Medicine Education and Training for Engineers and Scientists of the Future (hereafter, NH CREATES). This combination of stakeholder relationships and their activities, including teacher professional development and youth STEM projects, will establish an innovative ecosystem in New Hampshire that facilitates entry and retention of students in a biomedical education pipeline spanning middle school to higher education. This pipeline provides entry into the workforce critical to NH’s regenerative medicine, biofabrication and biotechnology needs, so that, in turn, this burgeoning industry can fulfill its potential to not only cure significant disease, but in time, evolve into that disruptive innovation that will transform medicine.